Regulation of Cell Fate during Kidney Development and Disease

SUMMARY
The overall goal of this “Pediatric Center of Excellence in Nephrology” is to provide a coordinated,
interdisciplinary approach to study the development of the kidney vasculature during embryonic, fetal and
postnatal life. The main theme of this Research Center is “Regulation of Cell Fate during Kidney Development
and Disease.” Broadly, the proposed research deals with fundamental questions of clinical relevance in Pediatric
Nephrology such as the understanding of the proper development, and the structural and functional maintenance
of the kidney vasculature in health and disease. The experimental approaches range from examination of
epigenetic mechanisms that control cell fate, plasticity, and identity and the cellular signals underlying the
phenotypic transformation that occurs when homeostasis is threatened in early life. Project 1 will investigate the
role of renin cell progenitors in the development and pathology of the kidney arterioles (R. Ariel Gomez and
Maria Luisa Sequeira Lopez). Project 2 will define how the TGFb/FGF2 axis controls the fate of renin and
vascular smooth muscle cells under conditions that threaten homeostasis in infancy (Patricio Ray, Agnes
Swiatecka-Urban and Jennifer Charlton). Pilot and Feasibility projects within the general theme of the Center
will be solicited at a national level from universities at large, the ASPN, the ASN and adult nephrology programs
with the objective to add new talent to the investigation of renal diseases in children. This will be done in
coordination with the other 2 PCENs to avoid overlap and guarantee the best outcome for each project. A cutting-
edge Core in Single Cell Epigenomics, Transcriptomics and Bioinformatics (Nathan Sheffield, Silvia
Medrano) will add scientific and technical expertise to individual laboratories within and outside the Center. The
Center will be supported by an Administrative Core which will allocate and distribute resources to Center
participants, implement the Opportunity Pool Program with procedures for soliciting and selecting candidates for
Pilot and Feasibility Awards, maintain a Center Website and an Enrichment / Educational program to provide
resources for support of research students, the development of repository data, workshops, seminars, and
symposia to enhance research in kidney development and disease. This Pediatric Center of Excellence in
Nephrology has the necessary expertise, diverse manpower, focus, commitment, and institutional support to
accomplish the proposed goals. It is anticipated that the Center of Excellence will lead to improved
management of infants and children with renal diseases and hypertension.

Public health relevance
NARRATIVE The burden of chronic kidney disease places enormous physical, psychological, social and economic stress on the affected children, their families and our society. This Pediatric Center of Excellence in Nephrology was designed to foster advances in knowledge, new methodologies, training and collaborations in an inclusive and diverse multidisciplinary environment to improve the management of infants and children with renal and urological diseases.